Intimate Partner Violence and Depression Trajectories from mid-Adolescence to Young Adulthood

PROJECT SUMMARY
Intimate partner violence (IPV) and depression are substantial public health challenges for U.S. adolescents,
and evidence suggests a clear link between IPV experiences and subsequent depression. Despite their co-
occurrence and grave implications, research has not sufficiently explored the nuances and longitudinal patterns
of these experiences. The proposed research study addresses the intersecting crises of IPV and depression,
focusing on adolescents' unique vulnerability and the consequences of these issues for their short- and long-
term well-being. This study leverages the nationally representative NEXT Generation Health Study (NEXT)
dataset, which spans seven years of longitudinal data collected annually (2010–2017) from a diverse sample of
2,780 adolescents aged 15 through 23. The study examines the longitudinal relationship between IPV and
depression via two specific aims. Aim 1) To identify and characterize subgroups of IPV experience from
mid- to late-adolescence for females and males separately. Using Latent Class Analysis, this aim seeks to
reveal distinct patterns of IPV experience during adolescence using the first four waves of the NEXT, which
measure various types of IPV, including verbal, psychological, physical, and sexual. Subsequently, various
background indicators (e.g., age, race/ethnicity, sexual orientation, household structure) will be explored as
predictors of subgroup membership. Because previous research points to sex-specific differences in IPV
experience, these analyses will be conducted separately for females and males. Aim 2) To examine
depression symptom trajectories and the relationship between IPV subgroups and depression
trajectories from mid-adolescence to young adulthood. Using dual trajectory modeling, this aim
investigates longitudinal trajectories of depression for the full NEXT sample, and then within identified IPV
subgroups, exploring variations in onset, duration, and severity of depression symptoms. It is hypothesized that
individuals in subgroups described by more severe, persistent IPV will exhibit higher, more persistent
depression trajectories over time compared to subgroups described by less persistent IPV experiences, with
background indicators influencing these relationships. This study addresses a major gap in knowledge of
the longitudinal relationship between adolescents’ IPV experiences and subsequent depression over
longer time periods during the critical transition from adolescence to young adulthood, reflecting
multiple NIH research priorities. Responsive to the NICHD Child Development and Behavior Branch’s strategic
plan theme of improving child and adolescent health and the transition to adulthood and NIMH’s priority for
mental health disparity research, this study will improve understanding of IPV and depression among
adolescents as they transition to young adulthood. Findings are valuable for tailoring interventions and policies,
as different subgroups may have unique risk factors or needs during this key transition period that has important
implications for adolescents’ future education, work, and well-being.

Public health relevance
PROJECT NARRATIVE The proposed research addresses a crucial gap in the understanding of two, interconnected crises among U.S. adolescents – intimate partner violence (IPV) and depression – by conducting longitudinal, person-centered analyses to identify distinct patterns of IPV experiences and depression symptom trajectories during the transition from mid-adolescence to young adulthood. Results will for the first time elucidate several key findings: 1) types and extent to which adolescents experience IPV; 2) longevity and degree to which adolescents who experience IPV also experience depression symptoms; 3) effect of adolescents’ IPV experiences on depression symptom trajectories into young adulthood; 4) how these findings contrast by sociodemographic and background indicators. Findings will identify adolescents with outreach needs for IPV and/or depression support, and precisely when the need is most dire.